MOLECULAR BASIS OF INHERITED IMMUNODEFICIENCY DISORDERS

The purpose of this study is to better understand the molecular basis of immunodeficiency in patients with inherited forms of severe combined immunodeficiency. Blood is obtained from patients and their relatives, cell lines are made and DNA is harvested. Southern blotting and cloning studies identify mutations in patients.